Family care to nursing home residents and state essential caregiver programs during the COVID-19 pandemic: impact on dementia care, outcomes, and disparities

Project Summary/Abstract
Approximately 6.5 million older adults in the United States currently live with Alzheimer's
Disease or Related Dementia (ADRD) and this number is projected to increase to 12.7 million
by 2050. Most persons with ADRD require nursing home (NH) care during the course of their
illness, and about 70% of them die in NHs. Among NH residents, almost 50% have a diagnosis
of ADRD. The risk of dementia is higher for racial/ethnic minorities than non-Hispanic whites,
and racial/ethnic minorities with ADRD experience higher levels of cognitive impairment and
higher prevalence of behavioral and psychiatric symptoms of dementia. Together, these
increase the risk of NH placement for racial/ethnic minority older adults, and the level of NH
care they need after placement. However, strong evidence suggests that racial/ethnic minority
NH residents with ADRD receive less adequate care (e.g. more feeding tube use) and have
worse health outcomes (e.g. higher hospitalization rate) than non-Hispanic white ADRD
residents. Informal care, or unpaid care provided by family members or friends, is common for
NH residents with and without ADRD. However, family care to NH residents was seriously
disrupted during the COVID-19 pandemic due to extended NH lockdown. To mitigate the
disrupted family care,18 states established essential caregiver (EC) programs during 2020-21
which allowed NH residents to have in-person access to family or other caregivers under
national public health emergency. This study proposes to determine (1) the impacts of informal
family care on the health outcomes of NH residents with and without ADRD, their family
caregivers, and racial/ethnic residents with ADRD; and (2) the associations of state EC
programs with informal caregiving during the COVID-19 pandemic, and with resident and family
caregiver health outcomes. This project will employ the 2008-22 Health and Retirement Study
(HRS) survey data and other existing data files to address study aims. Findings of the study will
provide critical insights into the role of family caregiving to the health of NH residents with ADRD
and their families, and into the potential impact of state policies designed to foster family
caregiving in NHs during future public health emergencies.

Public health relevance
Project Narrative This study proposes to determine the impacts of informal family care and state essential caregiver programs during the COVID-19 pandemic on the health outcomes of nursing home residents with and without Alzheimer's Disease or Related Dementia (ADRD), their family caregivers, and racial/ethnic residents with ADRD.